FACS Analysis and Cell Sorting

The FACS Analysis and Cell Sorting Core will perform all assays on specimens from patients and mice that relate to flow cytometry including analysis and cell sorting and Luminex-based studies. Since non-cancer investigators from Northwestern University have limited access to the FACSAria and studies that require substantial cell sorting are cost-prohibitive, the newly established FACS Analysis and Cell Sorting Core will markedly expand the capabilities of the PPG investigators by providing antibody cocktails, protocols, and expertise that will enhance and facilitate the currently funded research and potentially new studies.